MOLECULAR MECHANISM OF MYOSIN IX MOTILITY

The proposal is to express and study the function of the unconventional myosin IX. The applicant will express and characterize the motor and calmodulin binding domains of unconventional myosin. First, a complete kinetic study will be undertaken, followed by low resolution structural studies involving cryo-e.m.,and attempts to produce crystals for X-ray diffraction. In parallel, single molecule studies will be attempted to test the hypothesis that myosin IX is a single-headed processive motor. The structural studies and single molecule studies will involve collaborations with others labs, including labs within the Pennsylvania Muscle Institute. The project will provide the trainee to a variety of approaches necessary for the study of molecular motors, as well as address an interesting hypothesis for a unique member of the myosin family.